GENETIC ANALYSIS OF SLEEP AND DEPRESSION

Short REM latency is heritable for narcolepsy and depression. Individuals with narcolepsy almost all express HLA DR2/DQw1. If short REM latency in depression is associated with HLA expression, it would indicate that REM sleep itself may be regulated by genes in or around the MHC and/or that MHC-related genes may be involved in depression.